Nanofiber-based Delivery of Combined Immune-modulating Compounds to Minimize Infection and Enhance Wound Healing

Abstract (Parent Award)
Despite major efforts to keep operating rooms sterile, surgical site infections (SSIs) remain a serious and
stubborn problem, killing up to 8,200 patients a year in the U.S. Our long-term goal is to develop novel
therapies that effectively minimize risk of SSIs and promote wound healing. During the previous funding cycles
of this award, we have demonstrated that i) successful encapsulation and sustained release of vitamin D and
other immuno-modulating compounds induced higher cathelicidin antimicrobial peptide (CAMP) gene and
protein (hCAP18/LL-37) levels in immune cells and keratinocytes in cell culture, a human CAMP transgenic
mouse wound model and human skin explants; ii) topical vitamin D increased killing of Staphylococcus aureus
in a skin wound-infection model using our human CAMP transgenic mouse; and iii) exosomes secreted from
immune cells treated with vitamin D contained higher levels of hCAP18/LL-37. Furthermore, we developed a
novel gas-foaming expansion technique to fabricate improved 3D nanofiber scaffolds eluting vitamin D that
promoted immune cell infiltration, induced hCAP18/LL-37, decreased inflammation, and promoted
neovascularization and collagen deposition in human immune system-engrafted mice. Building on these
findings, and our preliminary data, the goal of our proposal focuses on the development of nanofiber-based
dressings for enhancing innate immunity. Our overarching hypothesis is that co-encapsulating
immunomodulating compounds with exosomes secreted from treated immune cells in 3D nanofiber scaffolds
will synergistically enhance protection against SSIs and promote wound healing better than either component
alone. To accomplish this, there are three specific aims: 1) Demonstrate efficient encapsulation and elution of
immunomodulating compounds from our improved 3D nanofiber scaffolds; 2) Determine the antimicrobial and
wound-healing efficacy of exosomes derived from primed or human CAMP transfected immune cells; and 3)
Demonstrate the efficacy of immunomodulating compounds and exosomes- co-incorporated 3D nanofiber
scaffolds to promote healing and prevent infection in our humanized transgenic mouse model and ex vivo
human skin explants. Building on work from our prior grant, we expect successful completion of the aims in this
renewal will lay a strong foundation for developing the next generation of novel therapeutic anti-infective wound
dressings that could greatly speed healing, reduce rates of SSIs and minimize development of antibiotic
resistance. We also expect these dressings could serve as effective treatments for traumatic and combat
related injuries.

Public health relevance
Project Narrative (Parent Award) Surgical site infections (SSIs) alone account for 20% of all healthcare-associated infections (HAIs) and approximately 160,000-300,000 SSIs occur each year in the United States. These infections account for about 8200 death and nearly $3.5-10 billion annually in additional healthcare costs. The application outlines a strategy to develop therapeutic anti-infective wound dressings that improve the host immune response to attack the pathogen on numerous fronts rather than a single front like traditional antibiotics.